Role of cardiac m6A methyltransferases

Project Summary
Human early-onset dilated cardiomyopathy (DCM) is associated with significant morbidity and mortality in utero
and after birth. The majority of DCM in fetus is considered to be idiopathic, with a strong association with genetic
mutations in sarcomeric genes. Pathogenic sarcomere protein variants often arise from post-transcriptional
regulation. However, whether post-transcriptional dysregulation contributes to the pathogenesis of DCM in fetus
has not been determined, presenting a significant knowledge gap to understand the etiology of early-onset DCM.
In eukaryotic mRNA, N6-methyl-adenosine (m6A) is the most abundant post-transcriptional modification and
affects mRNA processing (i.e., stability, splicing) and translation. m6A is deposited by the m6A methyltransferase
complex composed of several catalytic subunits including methyltransferase 3 (METTL3) and methyltransferase
14 (METTL14). METTL3 and METTL14 play important roles in adult heart injury and repair, although their
potential function during early myocardial development and whether their dysregulation contributes to the
pathogenesis of fetal DCM is undetermined. In this proposal, we will address this by leveraging mouse genetics,
biochemistry, molecular biology, RNA biology, and histology. First, we will determine the functions of METTL3
and METTL14 in embryonic mouse myocardium, and whether their loss in cardiomyocytes induces fetal DCM in
mice. Secondly, we will identify the underlying molecular mechanisms by which METTL3 and METTL14 regulate
mRNA fates and early sarcomerogenesis and myofibrillogenesis. Successful completion of the proposed study
will reveal key roles for the methyltransferases and post-transcriptomic profile of cardiac mRNAs during early
cardiac myogenesis, and uncover the novel pathogenesis of fetal DCM, and thus shed new lights on therapeutic
strategies.

Public health relevance
Project Narrative Early-onset dilated cardiomyopathy (DCM) in the fetus is highly associated with postnatal death and heart failure without heart transplantation, yet the genetic etiology and underlying mechanism remain elusive. The proposed research will uncover novel mechanisms that may establish the link between cardiac mRNA metabolism and early sarcomerogenesis in the developing heart. Our findings will shed new light on causes of fetal DCM, thus potentially providing new therapeutic treatment strategies.